SUFENTANIL CITRATE FOR TREATMENT OF CHRONIC PAIN

The purpose of the study is to evaluate the safety and usefulness of sufentanil, an opoid pain medication that is related to morphine, when given as a continuous infusion subcutaneously.